Novel Interplay of KILN and MKL1 in Vascular Pathophysiology

PROJECT SUMMARY
The major goal of this supplement project is to investigate whether deficiency of Myocardin related transcription
factor A (MRTFA, MKL1), a key activator of vascular pathologies, reduces the burden of Alzheimer’s disease
(AD) and AD-associated dementia. AD is a neurodegenerative condition and the most common cause of
dementia. Clinical intervention through targeting Aβ remains unsuccessful, indicating that the simplistic Aβ theory
is unable to account for the full mechanism behind AD. Indeed, recent studies from epidemiology, clinical
imaging, and animal studies collectively point to the critical role of vascular influence on AD pathogenesis,
particularly the contributory role of the impaired neurovascular unit (NVU), which results in decreased cerebral
blood flow (CBF) and thus chronic cerebral hypoperfusion (CCH). Recent advances also indicates that, beyond
Aβ, many unknown proteins also participate in Aβ aggregation and neuronal toxicity. As such, unveiling key
regulator(s) that influence both adverse cerebral vascular remodeling and abnormal neuronal protein
aggregation is of high demand for development of effective therapies for AD and AD-related dementias. In the
course of working on our parent grant, we found that MKL1 expression is robustly induced by and contributes to
aortic dissection and aneurysm via its potent role in activation of senescence and inflammation in VSMCs. Our
new data revealed that MKL1 protein is prone to ubiquitination, a process that facilitates protein misfolding and
abnormal aggregation. Consistently, a recent study showed that similar to Aβ, MKL1 is abnormally aggregated
in postmortem brains of Alzheimer's disease patients. This provocative finding not only links MKL1 with AD
pathology, but also suggests that MKL1 could facilitate Aβ aggregation and thus neuronal toxicity. We
hypothesize that MKL1 promotes AD and AD-associated dementia via two distinct pathways: by
promoting cerebral vascular pathological remodeling, leading to cerebral hypoperfusion and thus
vascular dementia; and by participating in the cascade of abnormal protein aggregation to exacerbate
Aβ neuronal toxicity. We will use the same mouse models that we have generated under our parent grant, and
a selective small molecule MKL1 inhibitor that we have successfully applied in our recent publication to test this
hypothesis through two specific aims. Aim 1 will determine the impact of MKL1 deficiency in VSMCs on cerebral
vascular pathophysiology and cognitive behavior using angiotensin II model. Aim 2 will determine the impact of
MKL1 systemic deficiency on the same measurements as in Aim 1 using bilateral common carotid artery stenosis
(BCAS) CCH mouse model. These studies will be the logical extension to those proposed in our parent grant,
the latter focuses on the interplay of MKL1 and lncRNA KILN in big arterial disease models. Successful
completion of this supplement could uncover a novel druggable target for AD and AD-associated vascular
dementia and provide a critical foundation for my future R01 application aiming to establish an integrative ‘neuro-
vasculocentric’ paradigm for the study and possible treatment of AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a devastating chronic brain complication with no effective treatment because of the complex causes of this disease. We discovered that a protein, called MKL1 (aka MRTFA), which is abundantly induced in and contributes to aortic aneurysm. This protein was recently found to be associated with AD pathology in patients. Our goal in this supplement is to answer the question if deficiency of MKL1 can reduce the burden of AD and AD-associated dementia using our established genetic mouse models and a pharmacologic inhibitor.